RANDOMIZED STUDY OF PEGYLATED RECOMBINANT HUMAN MEGAKARYOCYTE GROWTH

The purpose of this research is to evaluate the safety, the efficacy and the side effects of Pegylated Recombinant Human Megakaryocyte Growth and Development Factor (or MGDF - a protein substance that has been shown to regulate platelet production) vs a placebo (a substance that contains no active ingredients) in previously untreated nonsmall cell lung cancer patients before and/or after treatment with carboplatin and Paclitaxel. The effect of pegulated MGDF on the incidence of adverse events; changes in Karnofsky performance status will be determined.